The Structural and Molecular Basis of Blast-Induced Vascular Injury

Traumatic brain injury (TBI) has been a major cause of mortality and morbidity in the recent
conflicts in Iraq and Afghanistan. Much concern exists over the role of TBI in the chronic
cognitive and behavioral effects that can develop during or after military service. Most injuries in
the recent conflicts have been mild TBIs (mTBIs) due to blast exposure. Vascular damage is
well established as a significant component of blast injury. Indeed under the conditions of
exposure in the model under study at the histological level the cerebral vasculature seems to be
selectively vulnerable. Using micro computed tomography (CT) scanning we found that blast
induces widespread attenuation of the brain vasculature. In proteomic studies on isolated
microvascular preparations obtained two months following injury one of the most highly altered
proteins identified by mass spec (MS) was found to be glial fibrillary acidic protein (GFAP),
which was decreased by blast-­exposure. This finding was confirmed by Western blotting on
isolated microvascular preps. The loss of GFAP seemed to suggest that following blast injury
astrocytic endfeet were becoming detached from cerebral vessels and immunostaining of
isolated microvascular preps supported this speculation. Interestingly of the first 9 proteins
identified by MS several others were neuronal intermediate filament proteins including the
neurofilament heavy chain (NF-­H) and α-­ internexin, which like GFAP, were decreased following
blast injury. Loss of these proteins suggests that nerve terminals become detached from
cerebral vessels as well. Disrupted gliovascular and neurovascular connections could affect a
number of cerebral functions. The proposed studies will determine the chronic structural and
functional consequences of blast injury on the vasculature in a rat model of low-­level blast
exposure. The studies will utilize quantitative immunohistochemistry, stereology, electron
microscopy, Western blotting of isolated microvascular preps, micro CT scanning and behavior.
We will test the hypothesis that blast injury causes widespread loss of gliovascular and
neurovascular connections and determine the functional consequences. We will also determine
whether a treatment that improves the post-­traumatic stress disorder (PTSD)-­related behavioral
traits that develop in this model stimulates gliovascular and neurovascular connections as well
improves the vascular pathology observed on micro CT scanning. Three-­time points post-­
blast exposure will be examined (48 hours, 6 weeks and 8 months) to capture the evolution of
the injury from acute into subacute and chronic phases.

Public health relevance
Low- level blast overpressures induce altered gliovascular and neurovascular interactions. The proposed research is aimed at characterizing the structural, molecular and functional consequences of blast injury on the brain vasculature in a rat model of low- level blast exposure. The findings of this research may be used to develop new therapeutic strategies for the treatment of veterans affected by blast- related brain injury.